PHASE II STUDY OF SURAMIN IN METASTATIC BREAST CANCER

To assess the antitumor efficacy and the toxicity of Suramin in patients with metastatic breast cancer when doses are carefully adjusted using blood level monitoring.